Preclinical Core

Project Summary
The Preclinical Research Core (PRC) provides a centralized resource for investigators utilizing preclinical models
within Pennington Biomedical Research Center’s Metabolic Basis of Disease COBRE. The PRC supports
aspects of animal research, including experimental design, execution of in vivo procedures, access and training
in the use of state-of-the-art equipment for animal phenotyping, data analysis and interpretation, use of
genetically modified mouse lines, and general support in areas of animal health and regulatory compliance. The
overarching goal of the PRC is to unify and extend existing resources that currently support preclinical research
into a cohesive team that effectively mentors, trains, and supports COBRE investigators. Considering that each
of the COBRE research projects utilizes preclinical models, the mentoring, technical support and equipment
housed within the PRC should substantially enhance the productivity and innovation of each research project.